A Multi-skills Approach for Low Literate Adult Learners

Abstract
This is a three-year project designed to identify sources of reading and writing difficulty for
students in adult basic education (ABE) programs. According to the 2019 NCES survey, a
significant number of adults struggle to read at a level adequate to function effectively in our
society. The problem of adult illiteracy has a significant negative impact on job acquisition, civic
participation, and informed access to healthcare. Not surprisingly, the small but growing body of
research on this population of readers suggests that their reading behavior differs in significant
ways from that of children matched on reading achievement. Unfortunately, the basic research
foundation upon which to build assessment and intervention tools targeted to the unique
characteristics of adults learning to read is still greatly impoverished in relation to what is known
about children learning to read (NICHD, 2001). Thus, much of the intervention and assessment
material used in ABE programs is based upon what we know about children. This project will
expand the basic research foundation necessary to build effective assessment and intervention
programs targeted to the specific needs of this population. This project will compare the reading
and writing behavior of two groups of participants (adults with less than a 7th grade reading
level who are currently enrolled in ABE programs and children who are matched on reading
ability). Both groups will be matched on socio-economic factors and ethnic and racial
background. While phonological awareness is seen by many as the most important aspect of
literacy acquisition, the English system of writing is not purely alphabetic, rather, it is
morphophonemic; words are represented in writing according to their meanings as well as the
way they sound. Thus, this project will focus on the contributions of morphological factors as
they relate to reading and writing development. Furthermore, morphology has been identified as
one component of vocabulary depth. Depth refers to how much we know about particular words
compared to breadth which is how many words we know. The purpose of this study is to
investigate the role of morphology in vocabulary depth. We will use a multi-skills approach to
understand how morphological awareness and other aspects of vocabulary depth contribute to
reading comprehension, visual word recognition in silent reading while eye movements are
monitored, and writing in these two groups of learners. Performance across the two groups will
be compared to gain a more detailed understanding of the unique characteristics of the adult
learning to read.

Public health relevance
Narrative The problem of adult illiteracy serves as a barrier to health care and social support services. Adults are likely to encounter a number of health literacy tasks in their daily lives: fill a prescription, read preventative health articles, understand health insurance forms, and tend to their children’s health care. The 2003 National Assessment of Adult Literacy specifically addressed health literacy in their survey and found that 49% of adults who did not graduate from high school scored in the Below Basic category of health literacy compared to 15% who did have a high school diploma and 3% who graduated from college.